Defining the cardiomyocyte microdomain signaling landscape in cardiac hypertrophy

Abstract
Heart disease is the leading cause of death globally and poses an enormous public health and economic
burden. In the United States, prevalence and mortality due to heart failure have even increased in recent years,
underscoring the need for a greater understanding of pathophysiological signaling mechanisms that underlie
cardiac maladaptation. The cardiac myocyte is a highly specialized cell-type with a complex and unique
cytoarchitectural landscape. However, mechanisms that topologically orient intracellular signaling events in
cardiomyocytes remain ill-defined. While the roles of phosphorylation in cardiac signal transduction have been
studied for decades, very little is known regarding regulation of signaling by lipid modifications. Palmitoylation
or S-acylation, the reversible attachment of fatty acids onto protein cysteines, is an optimal mechanism to
regulate dynamic association of proteins with signaling complexes that nucleate at intracellular membranes. We
found that protein palmitoylation modulates localized signaling in cardiomyocytes and participates in cardiac
hypertrophy and failure. Specifically, our recent data indicate that palmitoylation of Ras-related C3 botulinum
toxin substrate 1 (Rac1) exerts profound spatiotemporal control of cardiomyocyte Rac1 signaling in vivo. The
small GTPase Rac1 is a critical regulator of pathogenic signaling and oxidative stress in cardiac hypertrophy,
heart failure, and cardiac arrhythmia that functions in part through regulation of the NADPH oxidase 2 (Nox2)
complex that regionally generates reactive oxygen species in response to hypertrophic stimulation. Here, we will
exploit regulation of localized Rac1 signaling in cardiomyocytes by palmitoylation to reveal the microscale
intracellular signal transduction landscape in cardiac hypertrophy. This proposal will test the central hypothesis
that palmitoylation of Rac1 targets signaling activity to discrete cardiomyocyte membrane microdomains to elicit
activation of unique effector pathways and pathophysiologic responses. In this application we will manipulate
Rac1 palmitoylation status in vivo in the context of cardiac hypertrophy to achieve the following aims: (1)
determine the role of Rac1 palmitoylation in cardiac hypertrophy, compartmentalization of Nox2 activity, and
oxidative stress and (2) uncover effectors and signaling pathways regulated by palmitoylated versus
depalmitoylated proteoforms of Rac1. We will achieve these aims in part using a novel mouse model with
inducible knock-in mutation of the Rac1 palmitoylation site (Rac1 Cys178Ser). These studies will establish a
paradigm for palmitoylation as a lipidation switch mechanism for spatially encoding cardiomyocyte signal
transduction circuitry and will identify pathogenic microdomain signaling events that may provide more targeted
vantage points for treatment of cardiac hypertrophy and heart failure.

Public health relevance
Project Narrative This project will uncover how signaling at cardiomyocyte intracellular membrane microdomains contributes to cardiac hypertrophy and heart failure. Although a number of signaling pathways have established roles in cardiac disease pathogenesis, the topography of hypertrophic signal transduction circuitry within the complex architecture of the adult cardiac myocyte is ill-defined. We will interrogate the functions of protein palmitoylation, a reversible lipid modification, in spatiotemporal regulation of compartmentalized signaling events in cardiomyocytes that may potentially be leveraged for the development of more targeted strategies to treat cardiac disease.